Mechanisms of the BRCA-network in tumorigenesis and therapeutic response

Mechanisms of the BRCA-network in Tumorigenesis and Therapeutic Response (OVERALL)
Abstract:
The faithful repair of DNA damage and efficient resolution of stalled replication forks are fundamental
mechanisms by which mammalian cells maintain DNA sequence fidelity and chromosomal integrity during DNA
replication and in response to exogenous DNA damage. Defects in DNA repair mechanisms not only contribute
to genomic instability and subsequent tumorigenesis, but also can alter the epigenetic landscape of cells and
impart therapeutic vulnerabilities that can be exploited clinically. The investigators participating in this P01 project
share common interests in understanding the mechanisms by which cells maintain genomic integrity to suppress
tumorigenesis, and in exposing tumor vulnerability to therapy based on mechanistic understandings of the
genomic consequences of impaired DNA repair. One particularly strong area of research offered by this team is
a multi-disciplinary approach to understanding the basic mechanisms by which the BRCA1-PALB2-BRCA2
complex and associated regulators participate in regulating DNA replication and repair choice. Regulators of the
BRCA-network include, 53BP1, RNF4, BARD1, TOPBP1, EHMT2 (G9a), MCM10, SLFN11 (mouse Slfn9), and
BCCIP. Some of these factors have been a long-standing research focus for investigators in the project team.
The research collaboration is formed around the central themes of how members of this large network of proteins
interface with each other to maintain genome integrity, suppress tumor development and modulate tumor
response to cancer therapy. Four projects, two Shared Resource Cores, and an Administrative Core are
proposed to achieve three scientific goals: 1) to reveal novel mechanisms by which the recruitment and function
of the BRCA1-PALB2-BRCA2 network is regulated by chromatin context mediated by methylation, sumoylation,
and ubiquitination; 2) to refine the roles of the BRCA network in DNA replication, tumor suppression and define
the genomic consequences of BRCA dysfunction; and 3) to explore new opportunities to target defects in the
BRCA network for therapeutics in medulloblastoma and breast cancer.

Public health relevance
Public Health Relevance Statement: The BRCA-mutant cancers retain key features of the underlying homologous recombination defect (HRD) or “BRCAness”, conferring a vulnerability to targeted therapies that induce replication stress and DNA damage. Our Program takes multidisciplinary approaches to better understand the mechanisms by which the BRCA network suppresses tumorigenesis and impacts therapeutic response, with a goal of improving the outcomes of tumors harboring HRD, which account for up to 12% of all human cancer cases.